NCCAT: National Center for CryoEM Access and Training--Screening Supplement

Project Summary/Abstract
The National Center for CryoEM Access and Training (NCCAT), based at the New York Structural
Biology Center, provides access to state-of-the-art cryo-electron microscopy (cryoEM) equipment. The
equipment and services include specimen preparation robots, high-end microscopes with direct
detectors, screening microscopes, and other ancillary equipment required to solve structures to the
highest possible resolution using cryoEM methods. A highly qualified technical team provides direct
support, guidance, and assistance, ensuring the highest quality structures are resolved quickly and
efficiently. A cross-training program offers training to users across the full spectrum of skill levels and
career goals.
This is a request for supplemental funding to support a grid preparation and screening (GPS) service
for cryo-transmission electron microscopy (cryoTEM) at NCCAT. The objective is to provide urgently
needed support to groups with limited experience in cryoEM methods and limited access to local
facilities. The goals will be to support these groups and get them started, while also training them in all
aspects of the methods so they can make the best use of every resource available to them as soon as
possible.

Public health relevance
Project Narrative CryoEM has unique capabilities for studying biological systems that are not accessible through other structural methods. Recent technical advances in single-particle cryoEM enable it to generate reliable atomic models of complete and fully functional macromolecular complexes imaged in near-native conditions. NCCAT provides nationwide access to state-of-the-art equipment, technical support, and cross-training to allow the production and analysis of high-resolution cryoEM structures. With access to appropriate equipment, cryoEM utility is only limited by the quality of the sample and the users’ experience, thus user training and prompt sample screening are key workflow components requiring dedicated resources and standardized procedures.